Integrated Health Sciences Facility Core

Project Summary (IHSFC)
The mission of the Mount Sinai Center on Health and Environment Across the LifeSpan (HEALS) is to
promote team-based environmental health science (EHS) research that embraces the developmental origins of
health and disease paradigm while adopting new initiatives in clinical research and a life course approach to
EHS. The Center will continue to foster environmental health studies on life-stage specific research by
providing expert guidance, and technologies, such as the “exposome”, novel teeth and hair biomarkers, and
satellite-based remote sensing for air pollution, light-at-night, greenness, and walkability, leveraging laboratory
and clinical resources. The Center will also have a focus on health promotion by promoting research in
ultraprocessed food chemicals within its membership and by supporting research in clinical populations that
have long been mainly studied through genetic approaches- such as children with Autism. A key element of
the P30 Center is the Integrated Health Sciences Facility Core (IHSFC). In keeping with the Center’s mission
to study environmental health over the lifespan, the IHSFC serves as a gateway to a variety of expertise and
resources under a single administrative umbrella. This structure provides an intellectual milieu that promotes
collaboration, as the IHSFC is the transdisciplinary “heart” of the Center and functions as a central hub through
which Center Members have access to multiple venues of service, from consultation on study design, research
technologies, and access to standard and novel exposure biomarkers and molecular testing. We also facilitate
access to biorepositories and clinical/ epidemiological populations. The overarching mission of the IHSFC is to
help investigators establish teams of collaborators who together will extend the boundaries of environmental
health sciences into research on chronic diseases. To achieve this, the IHSFC will provide consultations to
Center Members that leverage the ideal study design that can effectively study a research question, while
providing access to biomarkers that can facilitate EHS research. It will continue to develop innovative methods
to comprehensively measure past exposure to environment insults, facilitate access to clinical populations and
biospecimen archives and guide researchers to existing core services across Mount Sinai. The IHSFC will not
replicate services provided by other Mount Sinai core labs, such as those supported by our Clinical
Translational Science Award (CTSA). Rather, the IHSFC leverages and supplements CTSA resources to
facilitate access to multiple core lab assays and institutional biobanks(BioME). Overall, the IHSFC will be a
crucual resource that allows researchers to build highly efficient and collaborative teams that can positively
impact health across the lifespan through rigorous scientific research.